Using CAI to Enhance Drug Tx Staff HCV Knowledge and Communication Skills

DESCRIPTION (provided by applicant): To more efficiently meet the need and demand for hepatitis C virus (HCV) information and health communication skills among thousands of addiction counselors throughout the US, this project aims to adapt an effective, accredited, trainer-delivered HCV training ("STOP HEP C training") for addiction counselors into an interactive, tailored, self-paced, easily accessible, accredited, web-based computer-assisted instruction (CAI) program. Addiction counselors sorely need this information and these skills in view of the fact that of the 4 million HCV-infected people in the US (4 times as many as HIV!), the majority are former or current drug users who often lack critically needed medical support in their communities. As a consequence, when they enter drug treatment programs, most drug users are uneducated about HCV transmission and the potential dire consequences if HCV-infected. However, addiction counselors are optimally situated to support their clients'HCV related needs. While the NIDA-funded STOP HEP C training was developed and found to be effective in increasing counselors'HCV knowledge and health communication with clients, the demand for the STOP HEP C training far exceeds the capacity to deliver it in a trainer-facilitated format. The CAI offers an optimal way to disseminate this critically needed, evidence-based, and theoretically grounded training that retains its advantages and addresses its limitations in the current format while doing so at a reduced per-person cost of delivery. During Phase I, this project: 1) revised and updated the entire curriculum;2) adapted two of the STOP HEP C training modules into a CAI script;2) convened an Expert Advisory Panel that evaluated the CAI script;3) developed a self-directed prototype of the 2 modules: an introductory module with limited interactivity and an advanced highly interactive module individually tailored for either Drug Free Treatment Providers (DFTP) or Methadone-Maintenance Treatment Providers (MMTP);and 4) through qualitative and quantitative data analyses, assessed the learning effectiveness of the prototypes with a sample of potential consumers. This CAI will be superior to other currently available HCV trainings as it will provide information on health communication strategies;enable counselors to obtain counseling certification credits;be easily accessible, cost-effective, and self-paced;provide tailored information reflecting the treatment modality in which individual counselors work;and increase comprehension and retention of the material due to the interactive presentation of the information. The commercialization of the completed CAI will benefit from the secured support of regional and national associations serving addiction counselors, and businesses that have expertise in marketing health provider trainings and CAI products. In addition to sending product brochures to the extensive mailing lists of these businesses and associations, and placing advertisements on their websites with high exposure, we will market the CAI by demonstrating it at the national addiction provider conferences. PUBLIC HEALTH RELEVANCE: To more efficiently meet the need and demand for hepatitis C virus (HCV) information and health communication skills among thousands of addiction counselors throughout the US, this project aims to adapt an effective, accredited, trainer-delivered HCV training ("STOP HEP C training") for addiction counselors into an interactive, tailored, self-paced, easily accessible, accredited, web-based computer-assisted instruction (CAI) program. Addiction counselors sorely need this information and these skills in view of the fact that the majority of the 4 million HCV-infected people in the US (4 times as many as HIV) are former or current drug users who often lack critically needed medical support in their communities. This CAI will be superior to other currently available HCV trainings as it will provide information on health communication strategies;enable counselors to obtain counseling certification credits;be easily accessible, cost-effective, self-paced;provide tailored information reflecting the treatment modality in which individual counselors work;and increase comprehension and retention of the material due to the interactive presentation of the information.

Public health relevance
Public Health Relevance Statement. To more efficiently meet the need and demand for hepatitis C virus (HCV) information and health communication skills among thousands of addiction counselors throughout the US, this project aims to adapt an effective, accredited, trainer-delivered HCV training ("STOP HEP C training") for addiction counselors into an interactive, tailored, self-paced, easily accessible, accredited, web-based computer-assisted instruction (CAI) program. Addiction counselors sorely need this information and these skills in view of the fact that the majority of the 4 million HCV-infected people in the US (4 times as many as HIV) are former or current drug users who often lack critically needed medical support in their communities. This CAI will be superior to other currently available HCV trainings as it will provide information on health communication strategies; enable counselors to obtain counseling certification credits; be easily accessible, cost-effective, self-paced; provide tailored information reflecting the treatment modality in which individual counselors work; and increase comprehension and retention of the material due to the interactive presentation of the information.